Prediction of Anti-Cancer Medication Discontinuation via Patient Portal Messages and Structured Electronic Medical Records

Summary
Cancer is a leading cause of morbidity in the United States, with more than half a million deaths
estimated in 2019. Systemic cancer therapies are increasingly being designed as long-term oral
anti-cancer medications, given the increased convenience of a self-administered regimen. For
instance, patients with operable hormone-receptor-positive breast cancer are prescribed adjuvant
oral hormonal therapy, with an expectation that they continue their regimen for a minimum of 5
years to maximize the benefits. Although many oral therapies have proven effective in mitigating
cancer recurrence and mortality, discontinuation to these treatments are not uncommon. This is
a concern because medication discontinuation before the completion of a prescribed treatment
protocol leads to lower survival rates, increased risks of recurrence, and higher healthcare costs.
To improve treatment adherence and promise better healthcare delivery, it is essential for
healthcare providers to know when and why a cancer patient will discontinue their medications.
While there have been various investigations into regimen discontinuation, the focus of these
studies is either on knowledge discovery or intervention. While knowledge discovery focuses on
characterizing the potential factors that lead to medication discontinuation, intervention aims to
leverage discovered knowledge to design and test effective strategies to help patients adhere to
treatments. Because there are thousands of cancer patients, it is impossible for healthcare
providers to apply intervention to each of them. Limited medical resources need to be allocated
efficiently, such that patients with a higher risk of discontinuing medications will receive greater,
timely attention. Yet, the increasing integration of online communication and mobile computing
technologies into the healthcare domain are generating massive quantities of patient-generated
information. Thus, we propose to apply online patient-provider communications in a patient portal
to supplement traditional EMR data to better understand a cancer patient’s medical experience.
The central hypothesis of this project is that such communications together with structured EMRs
can be applied to learn and forecast oral anti-cancer medication discontinuation. The specific
aims of this project designed to test our central hypothesis are to 1) discover what has been
communicated in a patient portal; 2) infer how patient portal messages and structured EMRs are
associated with medication discontinuation; and 3) determine who are more likely to discontinue
medications. To the best of our knowledge, this is the first study to apply the messages in a patient
portal and structured EMRs to investigate medication discontinuation for cancer patients.

Public health relevance
Project Narrative Many oral anti-cancer medications have proven effective in preventing cancer recurrence and mortality, however, treatment adherence to these oral medications, some of which are taken for years, can be challenging for cancer patients due to a variety of factors, including side effects and high costs. Since medication discontinuation can lead to lower survival rates, increased risk of recurrence, and higher healthcare costs, society will benefit from gaining a deeper understanding of the causes of medication discontinuation and knowing who are at a high risk of medication discontinuation. In this project, we will analyze the online communications between patients and healthcare providers in a patient portal and apply them as well as structured electronic medical records to predict medication discontinuation.